Animal Core

ABSTRACT—ANIMAL CORE
The goal of the Center is to provide complex metabolic, physiologic, and behavioral phenotyping and
consulting services to characterize living mouse models on a fair fee-for-service basis. To do so requires a
Center to receive, house, feed, monitor, and maintain the health of mice submitted for phenotyping by
investigators. Therefore, the Animal Core will import and provide optimal husbandry care and high-quality
animal health services for mice sent and enrolled for testing at the Center, provide a number of specialty
services, including surgical manipulation services, molecular, and pathology, upon request, and make facilitate
access to disease-relevant mouse models from repositories or derive and create mouse models of diabetes
and/or obesity de novo for testing at the Center. The Animal Core will be staffed by a Leader, co-Leader, and
Core Coordinator.
The Animal Core will fulfill its mission by pursuing the following 3 Specific Aims:
Specific Aim 1: Receive, house, feed, monitor and maintain health of mice.
Specific Aim 2: Manage, organize, and coordinate movement of mice for phenotyping.
Specific Aim 3: Expand utilization of the Center to investigators with or without mice.
The Animal Core will have the institutional resources and authority to import and acclimate mice meeting
certain minimal health standards for further phenotypic analysis with minimal delay into dedicated vivarium
facilities. This high-throughput and multifunctional Core will broaden the availability of metabolic models and
phenotyping tests by enabling investigator mice to be analyzed, expediting data generation and interpretation,
and ultimately complete testing projects in a timely fashion and for reasonable cost.